FEASIBILITY STUDIES, CLINICAL TRIAL READINESS, GMP/CLINICAL TRIAL MATERIALS

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.”

Drug Manufacturing and Formulation Program; FEASIBILITY STUDIES; CLINICAL TRIAL READINESS; Good Manufacturing Practice; CLINICAL TRIAL MATERIALS